Connecting the Dots: HIV, COVID-19, and Structural Racism in Gender Minority Women

Project Summary/Abstract
Transgender women, particularly Black and Latina transgender women living with HIV, are
particularly vulnerable to the socioeconomic and psychosocial impacts of the COVID-19
pandemic. However, data are lacking on how the intersection of HIV, COVID-19, and structural
racism affect the physical health and psychosocial outcomes among transgender women.
Understanding these relationships and identifying factors that may modify them are important
steps towards advancing health equity. This study combines and supplements data from
existing NIH-funded prospective studies with transgender women (with and without HIV) to
assess longitudinal relationships between HIV and COVID-19 disease experiences and to
examine associations between structural racism, HIV, and pandemic-related health inequities
among transgender women. This innovative study will analyze data from 450 transgender
women to assess health outcomes along lines of race/ethnicity, HIV status, and technology
access. This innovative research will provide novel information that can be used to guide public
health efforts to reduce health disparities.

Public health relevance
Public Health Relevance Statement Transgender women are heavily impacted by HIV, COVID-19, and structural racism. However, data are lacking on how these intersecting pandemics affect physical health and psychosocial outcomes in this population. This study leverages existing NIH-funded prospective cohorts to assess these relationships and their potential effect modifiers toward to the goal of identifying intervenable factors to advance health equity.